High Content Screening for Bifunctional Chimera Biologics

SUMMARY
High content screening is one of most of the important advances in drug discovery. It has enabled
automated high-throughput discovery of many small-molecule drugs to treat human disease. However,
recent decades have seen the development of over 400 Biologic drugs based on proteins, rather than
chemical entities. Examples include insulin, erythropoietin, growth-factor inhibitors, and monoclonal
antibodies, which improve the Quality of Life and lifespan of millions of patients. Despite this impact,
there is no high content technology to screen cellular functions to create and assay new Biologic drugs.
Heligenics has developed the “GigaAssay” to characterize the activity of vast libraries of protein
variants. In previous studies of our SBIR projects, a specific GigaAssay was created to identify
soluble variants of Interferon, a family of proteins involved in immunity and auto-immunity, which are
used to treat Multiple Sclerosis. In this Direct Phase II proposal, we will extend the GigaAssay
approach to create and screen libraries of bifunctional Interferon chimeras for improved cell
stimulatory function. Bifunctional proteins have been recently developed as advanced treatments for
cancer, obesity, and diabetes, and many others are in clinical trials. These drugs are safer and
more efficacious than their mono-functional predecessors.
Many methods are available to create libraries of protein variants, but no platform exists for
high-throughput functional screening of libraries of protein families or chimeric Biologics. The
GigaAssay developed in previous studies allowed Heligenics to both generate and measure the
function of all possible single-residue substitutions or 1,000’s of chimeras at once. In Aim 1 of our
Direct Phase II proposal, we will evaluate a library of over 50,000 bi-functional Interferon chimeras
to isolate and test a more active protein product. In Aim 2, the most effective chimeras will be
confirmed in cell-based assays. In Aim 3, biological properties and disease-modifying activity of the
leads will be compared to FDA-approved Interferon drugs in a mouse model of Multiple Sclerosis.
Heligenics intends to develop the Interferon chimera leads and advance them to clinical trials with a major
pharmaceutical partner. Validation of the GigaAssay for high content screening in this SBIR Direct Phase II
project will establish this approach as a unique and powerful means to identify new bi-functional
protein chimeras for drug development.

Public health relevance
Narrative Interferons are anti-inflammatory proteins used as the first-line therapy to treat multiple sclerosis, cancer, autoimmune disorders, and antiviral therapies. Dual Agonist Chimera are an important emerging class of therapeutics; however, there are no chimeric drugs for Interferons. Heligenics proposes to adapt its GigaAssay technology to screen new double Interferon agonist chimera and pursue pre-IND studies in mouse models of multiple sclerosis.